PUTATIVE FUNCTIONS OF THE LIPOGENIC ENZYME ASPARTOACYLASE IN THE INTESTINE

ABSTRACT
Epithelial cells of the intestine perform metabolic reactions to sustain energy requirements for supporting gut
peptide secretion from hormone-producing enteroendocrine cells, carbohydrate and amino acid absorption by
enterocytes, lipid synthesis and storage, and cell turnover. Acetate, a precursor to acetyl-CoA, is an essential
intermediate metabolite driving vital cellular processes, including the TCA cycle and de novo lipogenesis. Acetate
can be generated from N-acetylaspartate (NAA), an essential brain metabolite for myelin lipids. The only enzyme
capable of cleaving NAA is aspartoacylase (ASPA), which generates acetate and aspartate. Although the
importance of NAA breakdown and ASPA is known in the brain, its function in other tissues is unknown. I found
that Aspa is highly expressed in the mid-villus enterocytes in the small intestine. I also demonstrated that
inducible whole-body knockout of Aspa in mice increases insulinotropic hormones after glucose administration
and that their ileum tissue harbors less aspartic acid. These observations, coupled with other literature, suggest
that ASPA expression contributes to the endocrine functions of the intestine and furnishes metabolites derived
from NAA within absorptive enterocytes. The goal of this proposal is to identify the fate of NAA-derived acetate
and aspartate in cells of the small intestine by understanding how altered ASPA expression affects hormone
secretion, enterocyte carbohydrate and lipid absorption, and cell turnover. To pursue this goal and to enhance
my training in intestine biology and metabolism, I designed two Aims. In Aim 1, I will define how Aspa deficiency
impacts gut hormones and nutrient metabolism using an intestine-specific Aspa knockout mouse model. In Aim
2, I will use intestine organoids to define how NAA hydrolysis contributes to intracellular pools of acetate and
aspartate. Completing this project will identify the novel function of ASPA and NAA in the intestine, identifying
insights into potential new cellular and metabolic functions of enterocytes and energy-carrying metabolites, which
are potential contributors to metabolic dysfunctions in digestive diseases.

Public health relevance
PROJECT NARRATIVE The small intestine is a major energy-consuming organ that supports digestive and endocrine functions. The metabolite N-acetylaspartate (NAA) is known to be involved in myelin lipid synthesis in the brain, but functions in the intestine remain unknown. This research pursues the functions of NAA in the intestine and how its accumulation in enterocytes contributes to energy metabolism.